2024 Pittsburgh International Lung Conference: From Smog to Social Equity: How the Exposome Shapes Our Respiratory Health

ABSTRACT
This application requests partial funding for the 2024 Pittsburgh International Lung Conference (PILC) “From
Smog to Social Equity: How the Exposome Shapes Our Respiratory Health.” The exposome is defined as
“The cumulative measure of environmental influences and associated biological responses throughout the
lifespan, including environmental exposures, diet, behavior, and endogenous processes.” Therefore, studying
the exposome requires collaboration among diverse fields such as environmental epidemiology, toxicology, and
basic science and represents both a timely and suitable topic for a multi-disciplinary conference on lung disease.
PILC 2024 will provide a platform for investigators from various disciplines related to the exposome to share
ideas, showcase technological innovations, and build collaborations. The conference program includes a
Keynote Presentation followed by six main sessions over two days focusing on indoor and outdoor air pollution,
the microbiome and the environment, smoking and e-cigarettes, climate change, basic to clinical translation, and
social determinants of health. Interspaced with these sessions are two panel discussions, including one focused
on career coaching for early career investigators, poster sessions, and a formal dinner with a presentation. The
conference organizers will facilitate interaction between participants, thought leaders, early career faculty, and
community providers throughout the conference. Speakers will include medical professionals (MDs, PhDs, and
RNs) from leading academic institutions. A plan to promote diversity, wellness, and a safe environment at the
conference is included. To our knowledge, no scientific conference of this kind has been organized in recent
years.
We propose the following aims: (1) To provide an inclusive, safe, and collaborative environment for
researchers to disseminate and discuss scientific advances in our understanding of the exposome as it relates
to pulmonary medicine. We aim to organize a meeting from September 19-20th, 2024, in Pittsburgh, PA, to
attract the top scientists in the field, early career faculty, trainees, and community providers, including women
and minorities. Interaction will be facilitated via panel discussions, question and answer sessions, dinner talks,
shared meals, and poster sessions. (2) To promote the interaction of students, clinical trainees, post-doctoral
trainees, and early career faculty with established investigators. Travel awards will be targeted toward trainees
and early career faculty. Essentially, all participants will be able to present a poster. Each of the six sessions will
feature a presentation from early career faculty (pre-K level). A panel discussion will be held where chiefs from
several pulmonary divisions will provide career coaching to trainees and early career faculty.

Public health relevance
NARRATIVE This application requests partial funding for the 2024 Pittsburgh International Lung Conference “From Smog to Social Equity: How the Exposome Shapes Our Respiratory Health.” Studying the exposome requires collaboration among diverse fields such as environmental epidemiology, toxicology, and basic science and represents both a timely and suitable topic for a multi-disciplinary conference on lung disease. The 2024 Pittsburgh International Lung Conference will provide a platform for investigators from various disciplines related to the exposome to share ideas, showcase technological innovations, and build collaborations.